Risk-stratified self-management care for colorectal cancer survivors: a new approach to increasing adherence to health behavior recommendations

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) incidence and mortality are strongly linked to modifiable lifestyle factors, e.g., physical
activity, alcohol intake, and diet. Importantly, adherence to health behavior recommendations (HBR) after CRC
diagnosis improves physical function, quality of life, and is consistently associated with longer survival.
However, <10% of CRC survivors adhere to health behavior recommendations (HBR) after diagnosis.
Addressing low adherence to HBR in CRC survivors is therefore a clinically relevant unmet need. Low
adherence to HBRs stems from a dearth of personally-tailored guidance about how to manage complex health
behavior change. Personalized self-management training can remedy this issue by teaching CRC survivors the
skills required to integrate health behavior recommendations into their unique life contexts. In non-cancer
populations such as diabetes and spinal cord injury, personalized self-management training programs have
been associated with increased adherence to health behavior recommendations when compared to
standardized interventions. To date, a personalized approach to lifestyle self-management has not yet been
tested in a cancer population. With strong evidence that post-diagnosis healthy lifestyle factors improve patient
outcomes, CRC is an important population in which to study the impact of self-management training on HBR
This five-year mentored research program for Dr. Alix Sleight aims to examine the effect of a personalized self-
management training program on the uptake of HBRs in CRC survivors. A total of 120 stage I-III CRC patients
diagnosed within 12 months will be recruited from the Cedars-Sinai Cancer Center and assessed using the
standardized World Cancer Research Fund/American Institute for Cancer Research (WCRF/AICR) Health
Behavior Adherence Scale. Patients with a WCRF/AICR score indicating low HBR adherence will be enrolled
and randomized to: 1) a personalized self-management intervention with a focus on health behaviors or 2) a
standardized health behavior education program. Each patient in the intervention group will receive content
tailored to their unique areas of low HBR adherence on the WCRF/AIRC Scale. Our pilot study (n=30)
demonstrated that a personalized self-management training intervention is feasible to implement, acceptable to
cancer survivors, and has potential to impact adherence to HBR. We therefore expect that a larger systematic
assessment of this intervention will show significant and clinically meaningful change in adherence to HBR.
The proposed career development program was designed to expand Dr. Sleight’s skillset in 1) behavioral
clinical trials, 2) biostatistics, and 3) implementation science. The training plan includes workshops and formal
coursework alongside guidance from a network of diverse mentors. Together with a supportive institutional
environment, this mentored research program will equip Dr. Sleight with the skills needed to develop and
conduct large-scale randomized controlled trials of personalized self-management interventions for HBR
adherence.

Public health relevance
PROJECT NARRATIVE Colorectal cancer (CRC) mortality is linked to modifiable health behaviors such as physical activity, alcohol intake, and diet; however, <10% of CRC survivors adhere to health behavior recommendations (HBR) after diagnosis. In non-cancer populations, personalized self-management training programs have been associated with increased adherence to HBR when compared to standardized interventions, but a personalized approach to lifestyle self-management has not yet been tested in a cancer population. This prospective, two-parallel-arm, randomized controlled trial will test whether a personalized self-management training intervention improves adherence to HBR among CRC patients when compared to a standardized health behavior education control.